Neuromechanical modeling of postural responses: Cortical mechanisms of balance impairments in Parkinson's disease

Our long-term goal is to advance our neuromechanical understanding of balance impairments in Parkinson’s
disease (PD) to enable mechanistic, personalized treatments to improve balance and reduce falls. In this
renewal, we seek to identify cortical activity metrics related to perceptual, cognitive, and muscle activity
impairments in PD, all of which we showed in the prior funding period to be associated with balance
impairments and/or fall history. Here we seek to understand neural circuit dysfunction underlying interactions
between non-motor and motor symptoms of PD that lead to balance impairments. We build on MPI Ting’s
expertise in the neuromechanics of reactive balance control, adding MPI Borich’s expertise in high-density
electroencephalography (HD-EEG) and neuroimaging. An innovation of the proposal is the use of a series of
support-surface perturbations during standing as a balance probe to identify potential electrophysiological
biomarkers of neural circuit dysfunction relevant to balance and mobility impairments in PD. Our recent and
preliminary studies demonstrate that the balance probe elicits large, wide-spread cortical activity patterns time-
locked to the loss and recovery of balance responses that can be compared within and across individuals on a
millisecond time scale. We hypothesize that increased cortical contributions to balance underlie perceptual-
motor and cognitive-motor interactions that impair mobility. Our objective is to identify precise spatiotemporal
cortical activity patterns underlying perceptual-motor (Aim 1) and cognitive-motor (Aim 2) interactions in PD
cortical contributions to muscle activity during balance control (Aim 3). We will use a whole-body perceptual
paradigm that enables us to concurrently assess cortical activity related to whole-body motion perception,
cognitive and motor set-shifting, as well as cortical drive to balance-correcting muscle activity. We predict
greater pre-perturbation beta (13-30 Hz) power during a perceptual task will be correlated with worse
perception in PD but not older adults OA without PD (Aim 1), less attenuation of cortical responses will be
associated with worse cognitive set-shifting in OA and PD (Aim 2), and that OA and PD will have different
cortically-driven antagonist muscle activity (Aim 3). Across Aims, we predict that these poorer functional
outcomes will also be associated with increased engagement of cortical areas during the balance probe and
lower clinical balance scores. Based on preliminary data, we predict dopamine medications in PD will increase
cortical engagement during the balance probe, and in support of our hypothesis, will further impair perceptual-
motor, cognitive-motor, and muscle activity outcomes. Finally, we will perform exploratory analyses of
electrophysiological outcomes with respect to fall history, prospective falls, and structural and functional
neuroimaging data. If successful, we will significantly advance the scientific framework and
electrophysiological approaches to enable precision-medicine strategies for personalized, mechanistic
assessments and interventions to improve the quality of life of those living with PD.

Public health relevance
Project Narrative Motor and non-motor impairments are linked to falls and a poor quality of life in individuals with Parkinson's Disease (PD). However, the underlying mechanisms remain poorly understood, limiting the avenues for treatment. This proposal will use mobile brain imaging to precisely measure brain activity during a laboratory- based balance assessment. We will identify individual variations in impaired brain function and their relationship to the poorly understood perceptual-motor and cognitive-motor impairments responsible for poor balance in PD. The technique has the potential to advance more personalized diagnosis and treatment to reduce falls for individuals living with PD.